Pediatric Heart Network Regents of the University of Michigan

ABSTRACT
This proposal leverages strengths across the University of Michigan to support the Michigan Congenital Heart
Center as a productive collaborator, leader, and innovator in advancing efforts of the Pediatric Heart Network
(PHN) toward improving care and outcomes of pediatric and congenital cardiovascular disease. Michigan
Congenital Heart Center investigators have played key roles in many prior and ongoing PHN studies, including
leading the Single Ventricle Reconstruction Trial (the first multicenter randomized trial in the pediatric cardiac
surgery), directing the biorepository for several PHN studies, and leading the PHN Integrated CARdiac Data
and Outcomes (iCARD) Collaborative. Continued participation of centers with strong clinical and research
infrastructure, and experience in leading multi-center collaborative research is needed to further the important
work of the PHN. In addition, there are new challenges in the current era, including conducting research more
efficiently, better utilizing the ever-increasing volume of healthcare data, and investigating novel therapies and
devices to drive further improvements in outcomes (particularly longer-term outcomes), and tailoring these to
specific clinical and genetic profiles. Our proposal has two aims – first, we aim to serve as a collaborative
participant and leader in furthering the work of the PHN to address important questions in pediatric and
congenital cardiovascular disease. Our track record of success, and unique and comprehensive resources,
infrastructure, and expertise will ensure our ability to participate fully across PHN studies and lead efficient and
collaborative research. In particular, our expertise specifically related to the study of novel therapies and
devices, assessment of longer-term outcomes (including neurodevelopment), and underlying genetic factors,
will allow us to lead efforts to address key questions in these areas. Our numerous faculty with independent
research funding, training resources, and mentoring expertise will foster our ability to compete successfully for
extramural research funding to further support PHN activities. Second, we aim to lead innovative data
integration and sharing efforts to foster novel and efficient PHN research. Our investigators have extensive
expertise in this area, including pioneering initial linkages across large datasets in the field (supported by
NHLBI R01 funding), and creating a state of the art platform to share information across centers within the
Pediatric Cardiac Critical Care Consortium (PC4). Through our leadership of the recently formed PHN iCARD
Collaborative, we will work to bring innovations in this area to the PHN, including integrating existing and
emerging data to allow novel studies otherwise not possible, and to support more efficient conduct of research.
Participation and leadership of the Michigan Congenital Heart Center will foster continued success of the PHN,
and allow the network to meet the challenges of the current healthcare and research environments to continue
to advance the treatment and outcomes of pediatric and congenital cardiovascular disease.

Public health relevance
NARRATIVE This proposal leverages strengths across the University of Michigan to support the Michigan Congenital Heart Center as a productive collaborator, leader, and innovator in advancing Pediatric Heart Network efforts toward improving care and outcomes of pediatric and congenital cardiovascular disease.